CONTINUOUS INFUSION CYCLOSPORINE IN MARROW TRANSPLANTATION FOR MYELODYSPLASIA

This study will evaluate the safety and efficacy of continuous infusion cyclosporine and 5 doses of methotrexate in the prophylaxis of acute graft vs. host disease.